Role of Lipid Droplets in Macrophages and their Consequences in Lupus

PROJECT SUMMARY/ABSTRACT
Lipid metabolism, including lipid synthesis and degradation, is essential for the immune system and cellular
functions. Lipid droplets (LDs) are major lipid storage organelles that modulate macrophage function and are a
potential therapeutic target. The molecular mechanisms that link LDs and macrophage functions are still poorly
understood. Systemic lupus erythematosus (SLE) is an autoimmune disease in which efferocytosis, or clearance
of apoptotic cells, by macrophages is impaired. Current medications for SLE rely on nonspecific
immunosuppressive drugs with severe toxicities, and new targeted approaches are necessary. Two ancient
innate molecules, high mobility group box 1 (HMGB1) and C1q, have unique features in SLE. In humans, C1q
deficiency is highly associated with SLE. Conversely, HMGB1, which functions to block efferocytosis, is
significantly elevated in the serum of approximately one third of patients with SLE. We identified an interaction
between C1q and HMGB1, demonstrating that exposure to both proteins polarizes monocytes to an anti-
inflammatory (M2-like) phenotype. We also showed that exposure to HMGB1 plus C1q enhances LD quantity in
M2-like macrophages compared with macrophages exposed to HMGB1 alone, which exhibit an M1-like
phenotype. We replicated our findings in alternatively activated (M2) macrophages differentiated from human
monocytes. The M2 macrophages had significantly more LDs than classically activated (M1) macrophages. In
addition, M2 and M2-like macrophages showed better engulfment of apoptotic cells than M1 and M1-like
macrophages. Based on these observations, we hypothesize that LDs carrying specific lipids and proteins in
M2 and M2-like macrophages support efferocytosis function in response to exposure to apoptotic cells. In this
proposal, we describe experiments to (i) characterize LDs in macrophage subsets, and (ii) determine if we can
change macrophage functionality by manipulating the content of LDs. In Aim 1, we will characterize LDs using
biochemical and histologic approaches based on quantitative mass spectrometry, lipidomics, proteomics, and
high-resolution imaging. In Aim 2, we will define how LDs from M2 macrophages are associated with
efferocytosis and determine if targeted LD modulation either in quantity or composition can shift macrophage
function. Collectively, we expect this work to uncover the connection between LDs and macrophage function and
to reveal a mechanism by which HMGB1 and C1q promote immune tolerance in macrophages. If our hypotheses
are correct, we will continue these studies to help pinpoint new therapeutic targets in SLE based on the
manipulation of LDs and macrophage function.

Public health relevance
PROJECT NARRATIVE Systemic lupus erythematosus (SLE) is an autoimmune disease characterized by inefficient clearance of apoptotic cells, termed efferocytosis. Lipid metabolism is linked to the efferocytosis function of macrophages, but the mechanism by which macrophages regulate lipid metabolism for efferocytosis is unknown. In this project, we will define how the quantity and composition of lipid droplets in macrophage subsets affect efferocytosis and determine if they can be manipulated to shift macrophage function for the treatment of SLE.